ACHIEVE GreatER: Addressing Cardiometabolic Health Inequities by Early PreVEntion in the Great LakEs Region

The Administrative Core brings together a multidisciplinary team of investigators and research support staff to focus on a strategy to build synergy and efficiency within and across three major research universities to focus on the amelioration of chronic cardiometabolic disease disparities. The Administrative Core will provide key oversight to ensure that the proposed ACHIEVE GREATER Center is a fully integrated, well-oiled machine that is successful in training the next generation of investigators, while conducting research that accomplishes the overall goal of improving lifespan by controlling major cardiometabolic risk factors that contribute to midlife mortality in populations who reside in Detroit and Cleveland. In order to coordinate these efforts, the Administrative Core manages operations, monitors progress toward Center goals and implements quality improvement strategies to resolve challenges, and facilitates communication to ensure timely progress toward Center goals, access to Core services and adherence to NIH regulations.

The following specific aims for the Administrative Core reflect these goals:

Aim 1. Provide fiscal and operations management for ACHIEVE GREATER, including all coordination and oversight for administration of the program within the Coordinating Center and amongst project leaders, Core directors, partner institutions, regional collaborators, and stakeholders.

Aim 2. Support the development, implementation and coordination of the ACHIEVE GREATER scientific agenda and streamline access to resources, including Administrative Core research services

Aim 3. Monitor progress and evaluate effectiveness of ACHIEVE GREATER, maintaining open communication with Core and project leadership as well as stakeholder advisors, with early intervention to improve the likelihood that the Center accomplishes its goals, when necessary.

Aim 4. Achieve sustainability, cultivating additional institutional, regional and national support for a permanent center.